Uncovering the modes and genetics of gut bacterial transmission

Mammals harbor hundreds of bacterial species in the gut that are deeply integrated with their
hosts’ metabolic, immune, and neuroendocrine systems. Before birth, mammals lack a defined
gut microbiota, which must be assembled anew in each host generation. Individuals acquire
their first inoculum from the mother during birth and are subsequently colonized throughout life
by bacteria from the external environment, including social contacts. However, the modes by
which specific gut bacterial lineages are transmitted between hosts remain poorly understood. It
currently remains unknown which, if any, gut bacterial lineages are faithfully inherited within
mammalian host lineages over multiple generations. Similarly, the relative contributions of
horizontal transmission through social interactions and shared environments are unclear.
Furthermore, the underlying genetic bases of bacterial transmission phenotypes have not been
discovered. Resolving these knowledge gaps is of critical significance for understanding the full
complement of genetic material inherited within mammalian lineages, the evolution of symbiosis
between gut bacteria and mammalian species, the community assembly of the gut microbiota
within individual mammals, and the spread of bacterial enteropathogens within mammalian
populations. Here, we propose to identify vertically and horizontally transmitted members of the
mouse gut microbiota (Aim 1) and to discover the genetic bases of gut bacterial transmission
phenotypes (Aim 2). In Aim 1, we will employ an innovative experimental system that utilizes
wild-derived outbred populations of mice reared in outdoor enclosures to disentangle the modes
of transmission within the gut microbiota. As part of this work, we will also develop new
approaches for assembling high-quality bacterial genomes from metagenomes that will provide
unprecedented opportunities to study dispersal of bacteria. In Aim 2, we will employ transposon-
insertion sequencing of gut bacterial lineages that disperse within and between germ-free
mouse lines reared in gnotobiotic isolators in order to identify the specific genes that underlie
gut bacterial transmission phenotypes. This work will focus on both vertically and horizontally
transmitted bacterial lineages identified by our previous work as well as by results of Aim 1.
Determining the genetic basis of gut bacterial transmission within and between mammalian
lineages has the potential to reshape understanding of the mechanisms and evolution of
bacterial dispersal strategies. In addition, Aim 2 will contribute substantially to the development
of functional genomics tools in mammalian gut bacteria. Cumulatively, the proposed work will
yield fundamental insights into the modes of gut bacterial transmission in mammals.

Public health relevance
All humans and other mammals acquire their gut bacterial communities throughout life from a variety of sources, including family, social contacts, and the external environment. Despite the significance for public health of transmission of gut bacteria, we do not understand the modes by which individual members of the gut microbiota are transmitted, and the genes that determine these transmission modes have not been discovered. The proposed work will combine methods from microbiology, animal experiments, and functional genomics to discover the transmission modes of the mouse gut microbiota and uncover the underlying genetics of bacterial transmission traits.